Quantifying the effect of biomechanical SUID risk factors on infant respiration

PROJECT SUMMARY
The leading cause of mortality for infants from 1–12 months is sudden unexpected infant death (SUID),
encompassing both suffocation-related deaths and sudden infant death syndrome. No single condition appears
to cause SUID, but many deaths occur within infant products not intended for sleep where suffocation likely
played a role. Retrospective fatality data identify contributing risk factors and hazard modes as biomechanical-
based factors including body position, infant product interaction, and feeding. However, researchers have yet
to quantify a relationship between these factors and infant respiration, leaving clinicians, parents, and
manufacturers of infant products with little evidence-based guidance on the best biomechanical practices to
avoid SUID. The proposed study would respond to this problem. It would also substantively advance the
biomechanics domain as the first to use biomechanics as the foundational science through which to study
SUID. We will bring a multidisciplinary team (infant biomechanics, juvenile product design and assessment,
computational modeling, pediatric pulmonology, and infant development) to this effort to untangle the complex
relationships between biomechanics and SUID. The goal of this research project is to significantly reduce
infant mortality by quantifying the respiratory effects from biomechanical SUID risk factors. The objective of our
study is to integrate in vivo human subjects biomechanics experiments and computational modeling to define
the relationships between respiration and biomechanical factors (body position, product interaction, and
feeding) which influence breathing. The central hypothesis is that biomechanical-related risk factors of SUID
affect younger and preterm infants more adversely than older or full-term infants. We will quantify relationships
between biomechanical factors and respiration via three specific aims: (1) Quantify relationship between infant
body position and breathing biomechanics, (2) Determine how product design features effect head/neck flexion
and trunk expansion using computational modeling, and (3) Evaluate effect of feeding on breathing
biomechanics in vivo. This project will provide a foundational understanding of how body position, product
features, and feeding affect infant breathing biomechanics, and will likely help flag the very real danger of
some infant products currently on the market. Deliverables include: (1) the first analysis of common body
positions on infant breathing biomechanics, (2) computational models to inform product designers and reduce
SUID risk, (3) characterization of breathing biomechanics changes after feeding to guide caregiving practices,
and (4) industry dissemination workshops. Collectively, these data would provide needed insight to advance
understanding of SUID-related deaths in relation to body position and daily life, and provide industry, parents,
and clinicians with the research upon which to inform biomechanics-based safe-sleep and infant care
guidelines.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it will quantify the influence of Sudden Unexpected Infant Death (SUID) biomechanical factors on respiration in infants. This study will provide a foundational understanding and translational knowledge for clinicians, parents, and infant product designers to reduce the risk of SUID from a novel biomechanics perspective.